Enhancing Support for Women w/Type 2 Diabetes: Follow-Up

DESCRIPTION (provided by applicant): Coronary heart disease (CHD) is the leading cause of death and functional limitations among women in the U.S. Postmenopausal women with diabetes are at especially high risk of CHD, but CHD research with this population is very limited. This proposal addresses the poorly understood "natural history" of long-term maintenance of change in multiple behaviors (i.e., dietary, physical activity, and stress management) related to CHD risk, as well as the effects of theoretically important mediating variables on relapse and maintenance. The proposed study is a continuation of a current research project that has already demonstrated significant and consistent positive effects of a lifestyle change intervention on reduction of behavioral CHD risk factors in a sample of postmenopausal women with type 2 diabetes. This research relies on a framework that synthesizes social-cognitive, social-ecologic, and goal-systems theories. For the current study, 279 postmenopausal women having type 2 diabetes were recruited and randomized into two groups: (1) usual care (assessment only) and (2) the Mediterranean Lifestyle Program (MLP), a comprehensive lifestyle change intervention. The MLP yielded significant behavioral, psychosocial, and physiologic outcomes at 6 and 12 months post-intervention. In the proposed assessment-only "natural history" continuation, the longer-term (3- to 7-year) effects of the MLP will be examined using a variety of statistical approaches, including state-of-the-art mediational and latent growth modeling techniques. In addition, the potential for translating this program into the real world will be assessed using the RE-AIM evaluation framework, a cost-effectiveness analysis will be conducted, and dissemination of the intervention will begin if it proves cost-effective. This proposal represents the next logical step in this line of research, as it examines long-term maintenance of behavior change and lays the groundwork for translation of this successful intervention into practice. It will also provide important scientific and theoretical information about the patterns of maintenance/relapse among multiple risk factors, and about the relative importance of theoretical mediating variables (self-efficacy; problem-solving; peer and community support).